Howard University Summer Research Education Experience Program in Oral Health

Howard University Summer Research Education Experience Program in Oral Health
Abstract
Despite advances in diagnosis and treatment, significant racial disparities in oral health persist, particularly
between African Americans and other ethnic groups. Increasing diversity in the oral health research and care
workforce is critical to improve the Nation's capacity to address and eliminate oral health disparities.
Howard University is a comprehensive, research-oriented, historically black private university. The student
body has traditionally been predominantly black (currently approximately 67%) and other underserved
minorities. The College of Dentistry is one of the two dental schools at a historically black college or university
in the United States and the only dental school in the Washington, DC, area providing dental health care to
primarily low-income populations. Since 2016, the College and Johns Hopkins University have jointly led a
summer research education experience program (SREEP), funded by the National Institute of Dental and
Craniofacial Research under PAR-13-104. During this time, 45 underrepresented minority undergraduate
students from Howard participated in the program. Thirteen of these students ultimately pursued postgraduate
training in the health science professions (5 in dentistry, 6 in medicine, 1 in a MD/Ph.D. program, and 1 in a
Ph.D. program) after graduating from their undergraduate programs. The PAR-13-104 program was not
renewable; therefore, we seek new funding to support and expand the SREEP.
We propose a SREEP at Howard University to engage, recruit, promote, and train Howard undergraduate
students from underrepresented minorities into oral health and health disparity research. The SREEP will be a
specialized didactic and mentored academic program with a series of formal and informal research and
education activities tailored to recruiting and training undergraduate students. Through the SREEP, we will
provide full-time eight-week-long summer research training for ten highly qualified students every year over the
5-year funding period.
To provide effective mentoring for the students, we will 1) develop a highly networked team of motivated and
skilled mentors from various disciplines by establishing a strong partnership between Howard and Johns
Hopkins Universities; and 2) develop an effective and sustainable research training and education
infrastructure by establishing a three-tiered mentoring system and executive, advising, and evaluation
committees. The three-tiered mentoring system involves matching each participating undergraduate to a
primary mentor with a basic, translational, clinical, community-based, or public health research focus at
Howard, a secondary senior mentor at Hopkins, and a career development mentor.
By participating in multi-disciplinary research projects and education events with experienced investigators who
will serve as mentors and role models, the students will gain valuable research experience and knowledge in
oral health and promote them into advanced education in oral health. Successful completion of this program
will have significantly impacted the dental, oral and craniofacial research and training environment at Howard
University College of Dentistry.

Public health relevance
Project Narrative We propose a full-time eight-week summer research experience program at Howard University, aiming at engaging, recruiting and training undergraduate students from underrepresented minority and other disparity populations into minority health care and oral health disparity research. The program is designed to be a specialized didactic and mentored academic program with tailed research and education activities. We will also develop a highly networked team of motivated and skilled mentors from various disciplines by establishing a strong partnership between Howard and Johns Hopkins Universities. By participating in multi-disciplinary research projects and education events, the students will gain valuable research experience and knowledge, and promote them into advanced education in oral health disparity.